Phosphotyrosine-mimicking peptides for the inhibition of the Src Homology 2 (SH2) Domain of the Signal Transducer and Activator of Transcription 3 (STAT3)

No change from parent award.

Public health relevance
No change from parent award.